Substance Use Disorders Treatment/Services Research Training Program

PROJECT SUMMARY / ABSTRACT
This UCSF postdoctoral training program, entering its 24th year, develops substance use disorders (SUD)
treatment and services researchers. The training focuses on four areas: a) clinical trials of behavioral,
pharmacological and psychosocial interventions, in both practice-based and community settings; b) services
research, including organizational change, in health care systems; c) psychosocial and biological factors that
interact with treatments, including genetics and neuroimaging; and d) treatment and services research in
complex, comorbid populations. Trainees are admitted for two years with possibility of a third year. The
exceptional trainee may enter for a one-year training program. To date the program has successfully trained 60
doctoral level psychologists, physicians, public health, and policy professionals for academic and research
careers. The program's graduates have embarked on fruitful careers to improve SUD treatment through
scientific study. In the most recent funding cycle the program focused on linking with mental health disciplines,
conducted rigorous program evaluation, extended its emphasis on technology, and enhanced its strength in
HIV health care and prevention. During the next five years we focus on technology; evolving opportunities
through health care reform; health care for underserved populations such as youth and sexual and racial/ethnic
minorities; and SUD and HIV prevention and care. The program is based in an environment with outstanding
and highly relevant resources, including linkages with diverse clinical sites and a variety of academic centers
and activities that supplement the training experience. The program is led by the Director and 4 Site Directors,
an Executive Committee of Investigators, and has guidance from a Scientific and Training Advisory Committee.
Core faculty members have backgrounds including psychology, psychiatry, biostatistics, nursing, public health,
and epidemiology. These faculty have strong histories of mentorship, extensive experience in obtaining
extramural funding, and ongoing research productivity in SUD treatment and services research. New faculty
members have joined the program, bringing important lines of inquiry, research settings, and methods. The
result is a scientifically productive environment that allows trainees to draw on multiple perspectives in
designing and completing treatment and services research. The expectation is that program graduates will
conduct independent, methodologically rigorous and clinically relevant SUD treatment and services research,
contributing to the knowledge base in the field.

Public health relevance
PROJECT NARRATIVE This training program at the University of California, San Francisco mentors the next generation of postdoctoral scientists in substance use disorder treatment and services research. As substance use disorders science develops, and more is learned about the behavioral, social, and genetic basis of this persistent disorder and the association with problems such as HIV and health disparities, investigators need postdoctoral training to master the skills and concepts essential to producing successful research. Consistent with our current training program we request support for 5 postdoctoral trainees at any given time, with the overarching goal of improving substance use disorders treatment by addressing the needs for both effective and efficient interventions for the many people affected by substance use disorders.